Comprehensive Research Training for Oral Health Sciences

Use continuation pages as needed to provide the required information Start with Principal Investigator. List all other key personnel in alphabetical order, last name first. Name Organization Frank A. Scannapieco University at Buffalo/Oral Biology Libuse Bobek University at Buffalo/Oral Biology Rosemary Dziak University at Buffalo/Oral Biology in the format shown below. Role on